Description of HIV social behavior using a phylogenetic model of structured co-evolution

PROJECT SUMMARY
Chronic viral and bacterial infections are characterized by pathogens that are difficult to control by the host
immune system and therapeutic interventions. Evasion of anti-infection mechanisms for a number of these
pathogens can be attributed to the formation of structured populations, comprised of highly organized pathogen
subgroups with specialized, cooperative functions. Pathogen communities, such as biofilms, can arise as a result
of replication, initiating with just one infectious particle. Effective persistence in the face of natural and synthetic
defenses, however, requires maintenance in the form of compensatory mutations that correct for deleterious
mutations favoring individual fitness over that of the population. These co-evolutionary events can be observed
over time via genomic sequencing of individual subgroups and, importantly, can be used to investigate unknown
biological pathways or mechanisms. HIV shares many characteristics with bacterial biofilms and other social
viruses, including chronic infection, antiretroviral resistance, and population structure among and within infected
host organs. Given these characteristics, it was not surprising to uncover initial evidence of across-tissue co-
evolution in the SIV-infected macaque model. In the absence of a cure for HIV infection, there is a critical need
to explore alternative behaviors that can explain HIV persistence and lead to novel therapeutic strategies. The
overarching objective of this proposal is to improve our understanding of the complex population dynamics
that characterize chronic HIV infection through 1) development of a novel statistical phylogenetic tool (GOSIP)
and framework, capable of reliably identifying cooperative behavior through compensatory evolution, and 2)
application of this tool/framework to full-genome sequence data available from an existing cohort of extensively
sampled SIV-infected macaques. The central hypothesis is that the implementation of a statistical graphical
modeling approach can accurately capture co-evolving sites in interacting subpopulations, including those of the
SIV intra-host population. The innovation of this project lies in its treatment of cooperative behavior as the
driving factor of the HIV population survival in the face of immune and therapeutic defenses, which can be
statistically inferred via a novel phylogenetic platform.

Public health relevance
PROJECT NARRATIVE The proposed research involves the development of a novel statistical phylogenetic tool for identification of pathogen social interactions and its potential application for treatment of HIV as a cooperative biosystem within the human host. Simulated compensatory mutations in a structured population, as well as publicly available, longitudinal genomic data from the SIV-infected macaque model will be used to validate the tool and test the central hypothesis surrounding HIV social behavior. The goal of this study is to improve our understanding of the interactions at the pathogen population level involved in immune evasion and drug resistance that plagues human health.